Promoting Reductions in Intersectional Stigma to Improve HIV Testing and PrEP Use Among Latino Sexual Minority Men

PROJECT SUMMARY
HIV prevention continuum disparities persist among Latinos in the U.S., especially those who are immigrants
and sexual minority men (SMM). Latinos tend to be diagnosed with HIV (i.e., tested) at a later disease stage
and use pre-exposure prophylaxis (PrEP) at much lower rates than do Whites. However, of the existing
evidence-based HIV prevention interventions, only one was developed for Latino SMM, and none have yet
been developed or assessed for PrEP uptake. Based on the scientific premise and empirical evidence that
stigma contributes meaningfully to HIV disparities, we propose to conduct a randomized controlled trial (RCT)
of an 8-session cognitive behavior therapy group intervention, Siempre Seguiré (“I will continue being”; named
by community stakeholders after a popular song conveying gay empowerment), which aims to increase
effective coping responses to stigma from intersectional identities (related to ethnicity, immigration status, and
sexual minority identity) among Latino SMM, with the goal of improving HIV prevention continuum outcomes.
Siempre Seguiré has a strong scientific basis in our prior pilot work, which found that the proposed intervention
is acceptable to key stakeholders, feasible to conduct, and associated with improved effective coping and
increased trust in providers and healthcare. The specific aims are: (1) To conduct a randomized controlled trial
of Siempre Seguiré, a culturally congruent cognitive behavior therapy group intervention for immigrant Latino
sexual minority men, to test intervention effects on regular HIV testing and PrEP uptake; (2) To examine
mechanisms of intervention effects on regular HIV testing and PrEP uptake, including more effective coping
(e.g., reduced internalized stigma, anticipated stigma, and medical mistrust); and (3) To conduct a cost-
effectiveness analysis of the intervention. In the context of an established community-academic partnership,
we will conduct the RCT with 300 immigrant Latino SMM, randomizing 150 to the intervention and 150 to an
attention control group (a community-based wellness-oriented support group, with sessions matched to the
intervention condition in number, timing, and length). Participants will complete surveys at baseline and 3, 6,
and 12 months post-baseline to assess the primary outcomes, potential mediators, covariates, and
moderators. Regular HIV testing will be confirmed with official copies of HIV testing results, and PrEP uptake
will be confirmed through copies of prescriptions, medical records, and urine testing. With the exception of our
own work, we are not aware of any interventions that address coping with stigma from intersecting identities in
order to improve health outcomes. Our research is consistent with Healthy People 2020, which recommends
developing interventions to address effects of stigma among sexual minority individuals. Although structural-
level interventions are critical for reducing societal stigma as a long-term strategy, individual-level
interventions—such as Siempre Seguiré—are needed in tandem to reduce stigma’s immediate health effects.

Public health relevance
PROJECT NARRATIVE Latinos in the U.S., especially those who are immigrants and sexual minority men (SMM), are highly affected by HIV-related disparities, tending to be diagnosed at a later disease stage, leading to delays in antiretroviral treatment use and lower rates of viral suppression. No culturally congruent interventions have been developed to address intersectional HIV-related stigmas, a key contributor to disparities in the HIV prevention continuum among Latino SMM. We propose a randomized controlled trial of an 8-session cognitive behavior therapy group intervention that aims to increase regular HIV testing and PrEP uptake by increasing effective coping responses to intersectional stigmas from ethnicity, immigration status, sexual minority identity, HIV, and PrEP among Latino SMM.